EPR OF CUPTSM

Copper pyruvaldehyde bis(N4-methyl-thiosemicarbazonato), CuPTSM, potentially can be labeled with copper radioisotopes. The labeled CuPTSM is attractive to use in positron emission tomography as a radiotracer. While results obtained from animal studies are promising, problems have been encountered in human studies. Our previous ESR studies have shown that CuPTSM is more strongly bound to human serum albumin (HSA) than to dog serum albumin (DSA). We attempted to determine the transport of CuPTSM from HSA to liposomes. The results indicated that about 70% of the CuPTSM can be transferred into liposome from HSA. CuPTSM has faster motion in liposomes than in HSA.